Developing a dynamic modeling framework for surveillance, prediction, and real-time resource allocation to reduce health disparities during Covid-19 and future pandemics

Project Summary
Black, Hispanic, and rural Americans are twice as likely to die from Coronavirus Disease 2019 (Covid-19). These health
disparities have been fueled by inadequate access to essential resources throughout the pandemic. Such inequities are not
unique to Covid-19. Over the past century, emerging infectious diseases have significantly perpetuated health disparities
in underserved communities. The interconnected pathways leading to these disparities, including heterogeneous disease
epidemiology, sociodemographic characteristics, and treatment access and uptake, remain understudied. Mobile health
clinics (MHC) are an effective and versatile tool for reducing health disparities through timely delivery of interventions to
medically underserved populations. However, the inability to effectively identify and prioritize high-risk communities has
posed daunting challenges for MHC decision makers and has led to suboptimal allocation strategies. To help improve the
efficiency of these field-level interventions and reduce health disparities during Covid-19 and future pandemics, our
proposal seeks to develop a modeling toolkit to improve infectious disease surveillance and prediction in underserved
populations and prioritize the delivery of essential resources to high-risk communities in real time. Our innovative,
multilevel modeling framework will utilize statistical models, machine learning, compartment-based and agent-based
models to reduce health disparities through 1) establishing a real-time data system feed for infectious disease surveillance
and estimation of disease epidemiology in underserved communities 2) identifying at-risk populations for allocation of
essential resources, 3) evaluating the complex interplay between sociodemographic and clinical characteristics, infectious
disease epidemiology, modifiable health barriers, and intervention uptake in order to improve emergency planning during
the Covid-19 pandemic and future health emergencies, and 4) establishing a modeling toolkit to inform delivery of
essential resources to underserved communities in real-time. This will be accomplished through real-time integration of
infectious disease outcome data, demographic, socioeconomic, and clinical characteristics, vaccine hesitancy surveys,
community-level contextual factors, and data on structural barriers to health care for estimation of key input parameters in
the dynamic simulation modeling framework. The framework we propose will be generalizable to other infectious
diseases, where model inputs will be disease and location dependent for swift translation to other public health problems.
To demonstrate the utility of our toolkit, our modeling framework will focus on delivery of Covid-19 mobile vaccination
clinics to underserved populations in South Carolina (SC). Our proposal will improve pandemic planning by developing
the modeling infrastructure for disease surveillance and understanding of infectious disease epidemiology in underserved
communities, ultimately improving timely delivery of essential resources to those of greatest need. Covid-19 has claimed
nearly 1 million American lives and has hospitalized over 4 million individuals through February 2022. Utilization of this
toolkit by public health decision makers can prevent thousands of future Covid-19 deaths. Through adaptation of input
data sources, our modeling framework is easily translatable to other infectious diseases and geographic regions and has
potential to save many more lives in future pandemics.

Public health relevance
Project Narrative This proposal will develop a dynamic simulation modeling framework for surveillance, prediction, and real-time allocation of essential resources to underserved communities in order to reduce health disparities during Covid-19 and future pandemics. Our flexible modeling framework will integrate real-time data on infectious disease outcomes with individual and community level contextual factors to inform infectious disease surveillance and improve understanding of disease epidemiology in underserved communities, and to support the decision-making process for resource allocation to high-risk populations. In collaboration with public health decision-makers, we will utilize our toolkit to inform real-time scheduling of South Carolina’s fleet of Covid-19 mobile vaccination clinics to underserved communities across the state; this has potential to save countless lives during the Covid-19 pandemic and will lay the foundation for effective resource allocation to underserved communities in other health emergencies.